Innovation in Measurement for Diet-Related Disease Research: Optimizing Utility and Reach to Reduce Health Disparities

Heart disease, cancer and diabetes are three of the 10 leading causes of death in the United States (US) and
all are diet-related diseases. Latinos are the largest immigrant population in the US but they share an uneven
burden of chronic disease including risk for cardiovascular disease, obesity and diabetes. Understanding the
factors related to disease risk and developing culturally-appropriate population-level interventions are critical to
reduce health disparities. Yet, such research is often stymied by the lack of measurement tools that are
specific, appropriate, and valid for diverse populations; poor measurement tools cloud our understanding of
disease-risk factors and may lead to inconclusive or wrong conclusions regarding the impact of interventions.
High-quality measurement tools are part of the essential infrastructure needed for understanding and
evaluating population health and advance the science of diet-related diseases. While myriad factors influence
diet-related chronic disease risk, food consumed at home accounts for half of all food expenditures among US
adults and represent the most proximal and modifiable factors that influence the foods and nutrients that
people consume on a daily basis. However, few valid home food environment assessment tools exist and none
have been validated with large, immigrant or low-literacy populations (i.e., limited understanding/use of the
written form of one’s native language). In 2008, our team developed and validated a Home Food Inventory
(HFI) to assess the healthfulness and obesity risk of home food environments using a checklist format. Our
user-administered HFI instrument has been used extensively in the field for NIH-funded studies by our team
and many others. Citation benchmarking statistics indicate our validation study article is in the top 2% globally
compared to similar articles. Yet, the original HFI can only be used with English-speaking populations, is quite
lengthy and paper-based. Our present objective is to further advance the science by developing an accessible
home food environment assessment toolkit that includes valid and reliable paper and multi-media electronic
tools targeting foods known to impact diet-related health that can be user-administered across literacy levels
and in English and Spanish. Our specific aims are to: 1) Reduce the original Home Food Inventory (HFI) into a
streamlined HFI-core instrument, maximizing utility and efficiency and minimizing participant burden while
retaining foods most impactful on diet-related health; 2) Evaluate the HFI-core (English and Spanish paper
versions) by assessing usability, acceptability, validity and reliability, and modify as needed; 3) Develop
electronic HFI-core tools (eHFI) that present audio and visual representation of foods for English speakers and
Spanish speakers in their native language to overcome language and literacy issues; 4) Evaluate both eHFI
tools by assessing usability, acceptability, reliability and validity, and modify as needed; and 5) Facilitate broad
use of the instruments through a permanent and easily-accessible storage platform and provide support and a
technological assistance platform for future language adaptations and testing.

Public health relevance
The foods and beverages people shop for and store in their homes are related to the foods they consume and the development of diet-related diseases such as obesity, cancer, cardiovascular disease and diabetes. Research to address health disparities in diet-related disease is critical but often stymied by the lack of measurement tools that are specific, appropriate, and valid for diverse populations such as Latinos. The proposed research will develop and make available a toolkit of valid home food inventories to use in diet- related health research to reduce health disparities among Latino and low-literacy populations.